Administrative Core

The Center for Pacific Innovations, Knowledge, and Opportunities (PIKO) will develop a robust clinical and
translational research (CTR) infrastructure for Hawaii to reduce health disparities among indigenous Pacific
People (IPP; i.e., Native Hawaiians, Other Pacific Islanders, and Filipinos) and other underserved populations in
Hawaii. PIKO is a partnership between the University of Hawaii (UH), Hawaii Pacific University (HPU), and
Chaminade University of Honolulu (CUH), and stakeholders serving IPP communities. PIKO takes a team-
science approach to transform current health promotion paradigms and to accelerate the pace of CTR advances
to improve IPP health and wellbeing. The PIKO Administrative (ADMIN) Core will function as a central
coordination and communication hub to maximize scientific innovations, facilitate interactions among partners,
foster idea-exchange, promote team science, enhance career development, and champion community
engagement; to coordinate the sharing of resources across existing NIH and NIGMS program grants at UH and
partnering institutions; to develop operational efficiencies to decrease administrative burdens on Core Directors
and pilot-funded investigators. The Specific Aims of the ADMIN Core are as follow:
Specific Aim 1: Oversee coordination of CTR activities and resource allocation by managing and
supervising all research, mentoring, and career development activities; by providing scientific and regulatory
oversight to be responsive to institutional and programmatic changes; by engaging the expertise of the advisory
committees and integrating their recommendations; by developing and managing operating policies and
procedures; and by ensuring scientific and fiscal flexibility by prioritizing and managing the allocation of fiscal
and other resources.
Specific Aim 2: Oversee strategic planning, inter-institutional coordination, and communication by
organizing and facilitating an annual strategic planning process to monitor progress and ensure milestones are
met within the proposed timelines; by fostering collaboration and interaction among participating institutions,
Cores, investigators, and other stakeholders; by coordinating sharing of resources between NIH-funded
programs and institutional infrastructure Cores; by managing conflict adjudication and dispute resolution
processes and procedures; and by managing all internal and external communication and dissemination
strategies to ensure effective and timely information exchange between PIKO’s partners, Core directors,
investigators, and staff.
At the end of the 5-year project period, PIKO will have expanded and diversified the CTR portfolio at UH and
partner institutions, increased efficiency and access to CTR Core operations, enhanced CTR productivity and
collaboration, heightened CTR competitiveness and grant award success, and accelerated the career
development of junior investigators and other CTR investigators, especially IPP investigators.